Competence of support cells to form hair cells in the mammalian inner ear

Summary/Abstract
In humans, loss of the hair cells in the inner ear leads to hearing and balance impairment, since these cells do
not regenerate. By contrast, in non-mammalian vertebrates, like birds and fish, damaged auditory hair cells are
regenerated very efficiently from the surrounding supporting cells. The ability of support cells to give rise to hair
cells through transdifferentiation was first demonstrated by Corwin in the amphibian lateral line, by direct
observation using time-lapse imaging, but more indirect methods also found a similar process to occur in bird
basilar papilla. These results together suggest that the problem of hair cell regeneration in the inner ear of the
mammal can be summarized in two fundamental questions: (1) What causes the loss in proliferation of support
cells following damage and (2) what limits the transdifferentiation of the support cells to new hair cells? In this
grant application we aim to study what are the factors that limit regeneration in the vestibular system of the
mammal. We will use various transgenic strains to activate pathways that may lead to stimulation of hair cell
regeneration. We will specifically direct our studies towards the crista (the sensory regions at the base of the
three semicircular canals) that detect head rotation in the three ordinal planes. As the population ages balance
disorders become more prevalent and this organ is particularly important for maintaining gaze. The cristae
have been understudied at the molecular level to date and we have recently developed a culture method and
are using advanced molecular techniques to elucidate changes in the competence of crista support cells to
generate hair cells.

Public health relevance
Project Narrative In humans, loss of the hair cells in the inner ear leads to hearing and balance impairment, since these cells do not regenerate, these problems affect an ever-increasing number of people as our population ages. This grant aims to explore the ability of the mammalian vestibular system to regenerate hair cells with particular emphasis on the competence of the support cells to convert to hair cells with Notch inhibition over post-natal time. We will look at several factors that may limit support cell plasticity including expression levels of genes in the Notch pathways, ability of support cells to respond to Atoh1, epigenetic factors that may also play a role and in addition hope to identify new pathways that may be manipulated to provide a treatment for balance disorders.